Cytoskeletal regulation of gut tube organogenesis and subsequent maturation of stem cell-derived islets

PROJECT SUMMARY
This proposal for a K01 Mentored Career Development Award details a Career Development Training Plan
and Research Strategy to facilitate the candidate’s transition to an independent investigator role in diabetes
research. In particular, the candidate’s long-term research goal is to make impactful discoveries that will enable
a cell-based therapy to become a viable and widely-used treatment option for type 1 diabetes (T1D), alleviating
the hardships and complications associated with this disease. To guide the candidate’s transition to
independence, the Career Development Training Plan integrates a scientific research proposal investigating
new aspects of β cell development and maturation, a mentoring team of experts in stem cell and β cell biology,
and the world-class research environment at Washington University in St. Louis.
T1D results from the selective autoimmune destruction of the insulin-producing β cells in pancreatic islets.
Studies have shown that transplanting human cadaveric pancreatic islets into T1D patients reduces or
eliminates the need for exogenous insulin injections, indicating that replacing the destroyed β cells can serve
as a functional cure for insulin-dependent diabetes. However, issues with human donor islet supply, quality,
and immunogenicity have limited the widespread use of this approach. In an effort to generate an unlimited
supply of highly functional islets for cell therapy, excellent progress has been made in the generation of stem
cell-derived islets (SC-islets) via direct differentiation protocols. In particular, these cells are able to replicate
the first and second phase insulin secretion kinetics of primary β cells, the ability to cure severely diabetic mice
within two weeks of transplantation, and further maturation after long-term transplantation. Despite these
remarkable advancements, current generation SC-islets still lag behind primary human islets in terms of insulin
secretion and overall islet composition.
Emerging evidence has demonstrated that microenvironmental cues (e.g., substrate composition and
mechanical properties) sensed by cells through their actin cytoskeleton play important signaling roles in cell
behavior and fate selection in several model systems, but actin’s role in the directed differentiation of hPSCs to
endodermal cell types has been very limited. To further enhance the specification to and maturation of SC-
islets using these principles, this proposal seeks to leverage microenvironmental cues transduced through the
actin cytoskeleton and its downstream pathways to improve pancreatic specification during gut tube
organogenesis as well as during endocrine cell maturation. These studies aim to improve specification to
pancreatic β cells, eliminate other undesired cell types (e.g., enterochromaffin cells), as well as enhance the
functional maturation and identity of these β cells. Successful completion of these objectives will not only
improve the clinical effectiveness of SC-islets but will also uncover fundamental insights into the biology of how
cytoskeletal state influences endodermal cell development.

Public health relevance
PROJECT NARRATIVE Transplantation of stem cell-derived islets (SC-islets) containing insulin-secreting β cells offers the potential for a functional cure for type 1 diabetes, as patients would no longer need to manage their blood sugar levels with insulin injections and intensive blood glucose monitoring. The primary goal of this research proposal is to improve the generation and function of these cells by elucidating the mechanisms by which a cell’s microenvironment and cytoskeletal state influence cell fate decisions during this process, providing strategies to further hone SC-islet differentiation techniques. This work, combined with my tailored Career Development Training Plan for this K01 award, will form the basis of my future research program as an independent investigator, which will aim to improve the clinical effectiveness of SC-islets as a cell-based therapy for treating type 1 diabetes.